AUTONOMIC RESPONSE TO PASSIVE UPRIGHT TILT IN MITRAL VALVE PROLAPSE

The aims of this study are to (1) identify parasympathetic and sympathetic responses to passive upright tilt in symptomatic patients with mitral valve prolapse; (2) to further characterize the differences in abnormal autonomic responses associated with hypotension; and (3) to examine the effect of volume loading on the autonomic and hemodynamic changes noted with upright tilt.